Functional Analysis of Mrgpr Family in itch sensation

Project Summary
The goal of our research is to understand the cellular and molecular mechanisms of chronic itch, a disease that
interferes with normal daily activity and can have serious clinical consequences. Many pathological conditions
can lead to chronic itch such as localized skin diseases or more systemic conditions like cholestasis and
kidney failure. Itch can also be a side effect of many therapeutic drugs. Current therapies including
antihistamines are ineffective in most chronic itch conditions suggesting the involvement of histamine
independent pathways. A major hurdle in understanding histamine-independent itch is the lack of knowledge
about the receptors directly activated by non-histaminergic stimuli. Primary sensory neurons in dorsal root
ganglia (DRG) play an essential role in detecting itch. Our lab has identified members of a G protein-coupled
receptor (GPCR) Mrgpr family that are specifically expressed in DRG and function as itch receptors. Recently
we showed that MrgprA1 in mice and its human homologue MRGPRX4 function as novel itch receptors,
detecting bilirubin and bile acids (BAs). More importantly, we demonstrated that MrgprA1/X4 play an essential
role for mediating cholestatic pruritus (itch), a condition resulting in elevated bilirubin and BAs due to bile duct
blockage. Our preliminary data suggest that MrgprA1 are novel receptors for various therapeutic drugs and
mediates drug-induced itch side effect. Preliminary data show that MrgprA1 also contributes to allergic contact
dermatitis (ACD). Furthermore, previous studies and our preliminary data suggest BAs are also mediators for
uremic pruritus. In this proposal, we will take a multidisciplinary approach to test the hypothesis that
MrgprA1/X4 are itch receptors and mediate itch caused by different disease conditions including medication
caused itch side effect, ACD, and kidney disease which dramatically impact the quality of patient's life and the
underlying mechanisms remain unclear. In Aim I, we will test the hypothesis that some of drugs with itch side
effect are pruritogens themselves by directly activating pruriceptive (itch sensing) neurons via MrgprA1 using
mouse genetics, pharmacology, in vitro Ca2+ imaging, electrophysiology, and in vivo DRG imaging. In Aim II,
we will test the hypothesis that MrgprA1 in sensory nerves and its peptide agonist NPFF released from nearby
mast cells in the skin contributes to ACD itch using different ACD mouse models combined with mouse
genetics and pharmacological approaches. In addition, we will determine whether pruriceptive neurons are
activated under ACD conditions and if so whether MrgprA1 and NPFF mediate the activation using in vivo
DRG GCaMP imaging. In Aim III, we will employ two uremic itch mouse models, an adenine-induced or a
uremic itch patient plasma injection model to test the hypothesis that BAs mediate uremic itch by activating
MRGPRX4 expressed in mouse DRG neurons. Moreover, we will identify other itch mediators present in
patient plasma who are receiving hemodialysis due to kidney failure. The results of this project will provide
insight into key itch mechanisms and open the door for the development of novel itch therapeutics.

Public health relevance
Project Narrative Chronic itch is a debilitating disease that can have serious clinical consequences. Our studies suggest that the sensory neuron expressed MrgprA1 and its human homolog MRGPRX4 are novel itch receptors and contribute to multiple chronic itch conditions including medication caused itch side effect, allergic contact dermatitis, and uremic itch. Therefore, functional analysis of MrgprA1/X4 will not only provide a mechanistic understanding of itch but also open new avenues for the development of novel itch therapeutics.